Durable Schistosome induced metabolic alterations to the myeloid lineage

PROJECT SUMMARY
Diabetic patients have a two-fold greater risk of developing cardiovascular disease than non-diabetic subjects,
and more than 65% of diabetic patients die from cardiovascular complications, thus, there is a critical need for
novel approaches to targeting insulin resistance, obesity, and atherosclerosis in this population. Recent
evidence has suggested that innate and/or adaptive inflammatory responses are associated with both insulin
resistance and obesity, while atherosclerosis is now widely accepted to be a lipid-dependent chronic
inflammatory disease. An increasing body of literature has established an inverse correlation between chronic
helminth infections and metabolic syndrome/diabetes. The central hypothesis of this project is that
schistosome antigenic exposure induces long-lived modifications in the monocyte/macrophage lineage that
lead to profound alterations in systemic phospholipid, cholesterol, and amino acid metabolism, resulting in a
protective state from the detrimental effects of High Fat Diet (HFD) (e.g., insulin insensitivity, and
atherosclerosis). The rationale for this research is that identifying genetic drivers that underlie this protective
phenotype is expected to enable the formulation and development of therapies to target these pathways as
treatments for diabetic patients at risk for CVD. This objective will be addressed by pursuing three specific
aims: 1) Define the role of S. mansoni infection in regulating the long-term metabolic and immunological
function of macrophages; 2) Determine how S. mansoni infection regulates hematopoietic differentiation of
macrophages at the transcriptional level; and 3) Determine the role of biological sex and sex hormones in
schistosome induced metabolic reprogramming. It is expected that the findings from these studies will provide
a definitive conceptual framework as to the mechanism through which S. mansoni infection modulates
metabolism and immunologic plasticity of the macrophage lineage.

Public health relevance
PROJECT NARRATIVE Diabetic patients are at serious risk of dying from cardiovascular causes (e.g., atherosclerosis) and the main risk factors for this are obesity and ongoing insulin resistance. It has recently been established that the rates of obesity, insulin resistance, and atherosclerosis are greatly reduced in areas of the world with chronic helminth infections. The purpose of this study is to determine the mechanisms behind helminth-induced alterations to the metabolism and immunologic function of macrophages, as well as how these modulations determine protection from the development of atherosclerosis and insulin resistance in a mouse model of high-fat diet induced atherosclerosis and obesity; with a long-term goal of identifying targets for new treatments of diabetes and atherosclerosis.